Administrative Core

Abstract
Core A: Program Administration
The mission of the Administrative core is to maintain a cohesive program through facilitating interactions
between the three projects and the investigators with the program director. Administrative assistance will be
given to the projects and cores to enable them to function efficiently and seamlessly across the Penn School of
Medicine, the School of Dental Medicine, and the Wistar Institute.
The Administrative core will organize the monthly lab group meetings at which the ongoing research will be
discussed. This core will also be responsible for organizing the Henle symposium, which will be a core part of
this program and provide a mechanism by which we can link this symposium with the external advisory
meetings. Thus, it will also be responsible for organizing all meetings of program leaders and the annual
meetings of the Internal and External advisory committees.
The Administrative core will be the conduit through which communications and materials will be exchanged
with external laboratories. The appropriate permits for transfer of infectious agents (C.D.C., U.S.D.A., and
F.D.A.) will be filed and maintained by the administrative core. All MTAs for the program investigators between
Penn and other institutions will also be handled by the administrative core.
The submission of manuscripts, progress reports, preparation of figures, review of presentations and posters
for meetings will also be expedited by the core.

Public health relevance
Narrative The administrative core will be the managing arm of the program project and will provide oversight of all administrative and scientific components of the four projects and cores. It will be responsible for organization of all meetings between the key personnel and leaders as well as internal and external advisory boards.